Clinical Assessment Core C

CORE C Abstract/Summary
The Clinical Assessment Core provides a range of services to Center investigators related to clinical
assessments. Specifically, the Clinical Assessment Core will: (1) provide to PMHARC-related studies clinical
and self-report behavioral assessments administered by highly trained core personnel; (2) provide
diagnostician recruitment, training, and ongoing calibration in order to maintain high quality; (3) oversee the
administration of a core battery in all Center pilot treatment studies and (where possible) R01s that includes
the Risk Assessment Battery, the BASIS-24, the PROMIS Depression scale, the PROMIS Social Roles scale,
and the Social Needs Scale; (4) provideconsultation on a broad range of behavioral, social determinants of
health, neuropsychological, and medication adherence measures to PMHARC investigators. By providing a
shared diagnostic assessment resource, the Clinical Assessment Core maximizes the quality of assessments
and minimizes cost for all Center investigators (diagnostic assessments are provided to PMHARC pilot studies
at no cost). By administering the same core battery measures across all studies, the Core is able to compile a
pooled database with substantially larger sample sizes. This larger database will enable Center investigators to
ask broader questions about the interactions of psychiatric status and HIV disease status and examine
subpopulations stratified by gender, race, and ethnicity.The Clinical Assessment Core will continuously monitor
and regularly evaluate each of the services that it will provide. Summary of the feedback from investigators will
be given to the Center Executive Committee, InternalAdvisory Board, and External Advisory Committee for
comments and suggestions. The Clinical Assessment Core will be directed by Mary Beth Gibbons, who has
extensive experience in the assessment of patients for psychiatric studies, and co- directed by Robert Gross,
who has extensive experience in the treatment of patients with HIV/AIDS and in assessing adherence to
medications, and Cobb Scott, who is experienced in the neuropsychological assessment of HIV+ patients.

Public health relevance
N/A